Yellow fever in Brazil: new insights on an old disease

ABSTRACT
Yellow fever virus (YFV) is widely distributed in the tropics of South America and Africa, being
responsible for massive yellow fever outbreaks causing deaths of thousands of people in recent years. YF
usually occurs in remote areas of Africa and the Americas where patients have little or no access to
advanced medical care and laboratory tests; therefore, much of what we know about YF in humans is very
limited including poorly understood epidemiology, pathogenesis, therapeutic approaches, and
host/virological determinants of disease during different phases of infection. In December 2016, a massive
sylvatic YF outbreak (2,155 human cases) took place in Southeast Brazil, with 46% of total cases (n=1,002)
and 37% of deaths (n=340) occuring in Minas Gerais state. From 2016 to 2018, a total of 299 confirmed YF
cases were admitted at Eduardo de Menezes Hospital, in Belo Horizonte, Minas Gerais. Our group has
maintained a database containing epidemiological and clinical data with long-term follow up from those
patients, as well a biological bank of clinical samples that can be probed to redefine the clinical course and
pathogenesis of this important pathogen. Our unique well-characterized cohorts include: (i) patients who
evolved to death; (ii) patients who recovered; (iii) patients who recovered and developed a novel clinical
syndrome named late hepatitis-like syndrome after yellow fever (LHep-YF); and (iv) patients who received
off-label treatment with sofosbuvir. Here we propose to (i) redefine the clinical course of YF and determine
the social, demographic, and co-morbid risk factors for severe presentations of disease, including
development of LHep-YF, (ii) investigate the viral and immunologic pathogenesis of YF throughout the
continuum of disease and (iii) predict YF prognosis by identifying virological and immunological biomarkers
associated with severe disease and assessing the effects of potential treatments. Our experienced
research team will take an interdisciplinary approach that integrates basic and applied virology,
immunology, epidemiology, and clinical infectious disease to fill important gaps on epidemiology, clinical
disease, pathophysiology, and biology of YFV. The recent YFV outbreaks in Southeast Brazil create an
unprecedented opportunity to analyze our unique bank of data and well-preserved samples from hundreds
of hospitalized YF patients. This information will be crucial for the establishment of protocols and more
applied studies to prevent morbidity and mortality from this important pathogen.

Public health relevance
Project Narrative Recent reports of massive yellow fever outbreaks causing deaths of thousands of people demonstrate that yellow fever is still a serious public health concern despite preventive vaccination. During the recent outbreaks in Minas Gerais, Brazil, we have maintained a database of information and samples from a large number of YF patients creating a unique opportunity to unravel yellow fever epidemiology, pathogenesis, therapeutic approaches, and host/virological/immunological determinants of disease. This proposal takes a holistic approach to investigation of YF using this unique biobank collected during different times of natural infection and throughout the convalescent phase of disease that will contribute to clinical care, targeted prevention and control of yellow fever.